Viral Neurobiology in the Prenatal Brain

ABSTRACT
The prenatal brain is uniquely susceptible to viral infections. Such infections threaten 1 in 4 pregnancies and can
cause severe neurodevelopmental disorders if not fetal demise. Different viruses lead to strikingly similar clinical
outcomes due to overlapping viral neuropathology and the host’s common neuronal response. Such a reality
calls for the development of urgently needed prenatal standards of care for prevention or treatment of virally
induced brain injury. This need requires a much-deeper understanding of the corresponding neurobiology.
A key regulator of the host’s common neuroviral response is the mechanistic target of rapamycin (mTOR) through
essential roles in viral autophagy, which affect viral clearance and neuronal survival. There is unsettled
controversy, however, about whether mTOR expression and viral autophagy are key defenses against, or
requisites to, viral replication and neuronal injury. The PI has new preliminary data connecting mTOR with a
novel neuroviral response gene, Hexosaminidase B (HEXB), and suggesting new cellular functions for this
genetic complex in activating prenatal viral autophagy to prevent brain injury. Opening new research windows
for therapeutic intervention, this sets the context for the proposed K08 study, which rigorously tests the guiding
hypothesis that neurodevelopmental gene expression affects prenatal viral susceptibility toward brain injury.
Purusing three integrated and synergistic aims in cellular, mouse, and human systems, the PI will investige how
gene expression of mTOR and HEXB affects prenatal viral susceptibility and how it might be altered to prevent
brain injury. First, human-derived organoids are used to study how expression of mTOR and HEXB affects viral
clearance, neuronal survival, and up/downstream pathways (Aim 1). In parallel, this relationship is prenatally
evaluated in vivo to determine its impact on postnatal development (Aim 2). Mirrored allelic series of mTOR and
HEXB are genetically cross-titrated in these aims, which will shed light on a population genomic analysis to study
the extent to which variants in these genes/pathways affect prenatal susceptibility to brain injury (Aim 3).
This K08 grant combines research using synergistic/integrated systems with theoretical and technical training
by seasoned mentors in neurobiology, neurovirology, and genomics at Children’s National Hospital and NINDS.
The individually tailored career development plan uniquely positions the PI, a board-certified prenatal-neonatal
critical care neurologist-scientist, to open multiple new research windows into the developing human brain by:
(a) deepening our fundamental understanding of prenatal neurovirology and the crticial role of neuro-
developmental genes (mTOR & HEXB), regulatory networks, and essential cellular functions; (b) examining
genetic regulation of prenatal viral autophagy as a cornerstone for prenatal precision medicine; and (c) tapping
into a robust neuroepidemiology research infrastructure (Consortium, CDC, NIH) to identify prenatal
susceptibilities. The ultimate goal is to understand the connection between viral neurobiology and neuronal injury
in the developing brain to optimize the neuropsychological life experience of future generations of children.

Public health relevance
PROJECT NARRATIVE Viral infections in the prenatal brain lead to severe injury and neurodevelopmental disorders, including cerebral palsy, global developmental delay, epilepsy, and other life-shortening disabilities. Currently, there are no preventive strategies and only few targeted therapies are available for prenatal viral infections. This work will investigate how two neuroviral candidate genes, mTOR and HEXB, regualte prenatal viral autophagy and neuronal survival by integrating novel systems modeling, lab studies, and clinical analyses; its long-term goal is to identify precision therapies for mitigating viral and other risks to the developing prenatal brain.